The impact of social determinants, conditional cash transfers and primary health care on HIV/AIDS: an integrated retrospective and forecasting approach based on a cohort of 100 million Brazilians

Proposal Title: The impact of social determinants, conditional cash transfers and primary health care on
HIV/AIDS: an integrated retrospective and forecasting approach based on a cohort of 100 million Brazilians
Project Summary
Considerable progress has been made in controlling many aspects of the HIV/AIDS epidemic. But
challenges remain in terms of scaling up successful national programs. This study will contribute to
knowledge on the impact of large-scale initiatives addressing both the social and medical determinants of
HIV/AIDS by combining data from Brazil’s national HIV/AIDS registry with other largescale databases
including the “100 Million Brazilian Cohort”: a virtual cohort of more than 100 million individuals over 18
years obtained by the linkage of large countrywide socioeconomic and health datasets. It will be the first
study to follow such a large number of individuals over time and in non-experimental conditions to
understand how social determinants, conditional cash transfers and primary health care affect HIV/AIDS
incidence, hospitalization and mortality; and how receipt of social protections at the individual level affects
HIV/AIDS outcomes (ART adherence and mortality). Thanks to the unprecedented dimension of the
dataset and the methods proposed, we will assess impact heterogeneities of the two interventions in a
large range of different subpopulations, as well as possible synergistic effects. Using the longitudinal aspect
of the cohort we will explore and assess in depth expected and unexpected dynamics, lagged and long-
term effects of changes in living conditions and in exposures to conditional cash transfers and community-
based primary health care. We will then expand the cohort and integrate estimates from the retrospective
evaluations with the development of forecasting for several alternative policy scenarios. Using an
innovative joined microsimulation and agent-based model we will be able to forecast the effects of the
current Brazilian economic crisis, overall and for several subpopulations, on the HIV/AIDS epidemic. We
will forecast and compare the impact of a wide range of alternative policy scenarios, such as the
maintenance of current levels of support of conditional cash transfer and primary care, reductions of
coverage and benefits due to fiscal austerity measures, or expansion in different subpopulation and with
different dynamics. We will calibrate and select the combinations of policy response able to maximize the
benefits on the HIV/AIDS epidemic, even during an economic crisis. The empirical results and the
innovative mathematical models produced in this project will represent an essential contribution to the
understanding and control of HIV/AIDS in lower and middle income country settings, as well as for
vulnerable populations in the United States.

Public health relevance
Proposal Title: The impact of social determinants, conditional cash transfers and primary health care on HIV/AIDS: an integrated retrospective and forecasting approach based on a cohort of 100 million Brazilians Project Narrative Despite considerable progress has been made in controlling HIV/AIDS epidemics in several countries, challenges remain in terms of scaling up successful national programs. This study will use one of the largest longitudinal dataset from the linkage of socioeconomic and health data to evaluate the effects of socioeconomic determinants, cash transfer programmes and primary care on the incidence, hospitalization, adherence to treatment and mortality from HIV/AIDS. Innovative mathematical models will be created to forecast the impact of alternative scenarios and identify the best policy options to reduce the burden of the disease. Results are expected to inform national efforts to maintain progress made in controlling HIV/AIDS in Brazil and demonstrate potential strengths and weaknesses of such programs in other countries experiencing challenges in sustaining HIV/AIDS, health care, and social protection programs, including the United States.